Out of the shadows: Illuminating mammalian histidine phosphorylation

Project Summary
Protein histidine phosphorylation plays an important role in several key signaling pathways in
mammals but is very poorly understood. The main reasons for this dearth of information about
histidine phosphorylation are the relative instability of pHis as compared to pSer, pThr, and pTyr
and a complete lack of chemical tools available to monitor and modulate the enzymes involved
in histidine phosphorylation and dephosphorylation. The Barrios laboratory is working to develop
fluorogenic assays that can be applied to monitoring cellular histidine phosphatase and histidine
kinase activity and to develop the first inhibitors of mammalian histidine phosphatase and
histidine kinase activity. We will investigate the structural and sequence contexts that facilitate
histidine phosphorylation and stabilize the resulting pHis residue and characterize the effects
that histidine phosphorylation has on protein structure and function, including enzymatic activity
and ability to bind metal ions. The tools, fundamental insights, and specific examples developed
in this work will facilitate future research into the biological roles of the histidine phosphatases
and kinases and are expected to revolutionize the field. The ultimate goal of the work is to
elucidate the roles that histidine kinases and phosphatases play in cellular signaling, health, and
disease and to identify promising therapeutic targets and lead compounds that act on histidine
phosphorylation pathways.

Public health relevance
Project Narrative The histidine kinases and histidine phosphatases are a poorly understood family of enzymes that play critical roles in G-protein signaling, ion conduction, central metabolism and chromatin biology and have been implicated in diseases as diverse as cardiovascular disease and cancer. The main barrier to a better understanding of these enzymes is a lack of tools available to study them. Research in the Barrios lab is focused on developing the tools necessary to study the enzymes involved in histidine phosphorylation and dephosphorylation, including cell-compatible fluorogenic substrates and targeted inhibitors. In addition, we are investigating the context cues that facilitate histidine phosphorylation and the impact of histidine phosphorylation on protein structure and function.